DIGITAL INCENTIVE SPIROMETRY EXERCISER TO IMPROVE PATIENT ADHERENCE AND CLINICAL WORKFLOWS

ABSTRACT
Lung complications occur in 1 in 20 people that receive a surgery that requires an overnight stay in the
hospital, even if their surgery is not near the lungs. Anesthesia during surgery and inactivity during recovery
cause air sacs in the lungs to deflate, which puts patients at risk of complications like pneumonia that increase
mortality five-fold, increase lengths of stay and recovery periods, and are both costly and non-reimbursable.
The current standard of care is to prevent lung complications with use of incentive, or therapeutic, spirometry,
where patients must breathe in from an incentive spirometer device 10x each hour to inflate their alveoli.
Proper incentive spirometry can prevent 1 in 3 post-surgery lung complications. However, current incentive
spirometers are entirely mechanical, making it difficult for nurses to track patient adherence to their exercises
beyond labor-intensive bedside monitoring. The majority of incentive spirometry is currently self-monitored and
self-reported by patients, which leads to poor adherence and overreporting. This makes incentive spirometry
largely inefficient and ineffective in the clinic today. Airalux seeks to solve this problem with a redesigned
incentive spirometer that can automatically collect user metrics and display them on a mobile dashboard for
clinician monitoring. The Airalux device is also designed to increase incentive spirometry adherence through
behavioral nudges and goal setting for patients. We have developed a unique combination of sensors,
mechanical design, and a software suite that can directly measure patient airflow and does not rely on the
mechanical piston systems of current incentive spirometers, which are clunky, difficult to digitize, and introduce
large opportunities for user error. The goal of this technology is to make incentive spirometry easy for patients
to use and easy for clinicians to monitor. The aims of this project are to develop a prototype with reduced
materials costs that make it viable and affordable for clinical use. Because this technology relies on
environmentally sensitive sensor configurations, we must also verify that our reduced-cost device can measure
inhalation volumes accurately in a broader range of environmental settings. This will enable advancement of
our technology to Phase II, when we will conduct a randomized clinical trial with patients using our lower cost
prototype and assess clinical outcomes from increased adherence, such as improved oxygenation and
reduced complication rates. Commercially, this device seeks to improve patient outcomes after surgery, while
also saving hospitals non-reimbursable costs associated with lung complication treatment and readmissions.

Public health relevance
PROJECT NARRATIVE In this SBIR, Airalux Medical plans to develop a digital incentive spirometer that improves patient adherence to the standard of preventative care for lung complications after any major surgery. Currently, incentive spirometry is labor-intensive to administer and monitor and relies on patient-led self-monitoring and self-reporting, resulting in poor adherence and poor clinical outcomes. This research aims to develop cost-effective automation of incentive spirometry exercise guidance, reminders, and data collection to actualize known clinical benefits of improved patient adherence for hospital systems and facilitate timely clinical interventions to lung complication prevention and treatment.